Optimizing HIV Care in Less Developed Countries

Project Summary/Abstract
Despite improved access to HIV testing and antiretroviral therapy over the past decade, people with HIV
globally continue to experience high mortality from HIV-associated infections such as cryptococcal
meningitis. Cryptococcal meningitis causes more than 90,000 deaths annually, 75% of which occur in sub-
Saharan Africa. Most of these deaths would be preventable with improved access to high-quality
diagnostics and safe, effective treatment regimens. However, mortality from cryptococcal meningitis remains
unacceptably high (70%-80%) due to challenges including unreliable supply of diagnostic tests, low testing
rates among at-risk individuals, lack of equipment and trained staff to perform diagnostic tests, limited access
to more effective treatments, and high drug and hospitalization costs for people with cryptococcal meningitis. It
is critically important to determine which specific interventions would be most effective to improve access to
cryptococcal meningitis testing and treatment and reduce cryptococcal meningitis-related mortality, given
budget constraints in resource-limited settings.
In the parent R37 (R37AI058736), the PI (Dr. Kenneth Freedberg) and research team have developed and
utilized the Cost-Effectiveness of Preventing AIDS Complications International (CEPAC-I) model, a
computer microsimulation of the natural history, clinical management, outcomes, costs, and cost-
effectiveness of HIV treatment. Past and ongoing analyses have included a focus on HIV testing, treatment,
and prevention strategies in multiple international settings. This administrative supplement proposes to: 1)
expand the CEPAC-I model to include the clinical outcomes and costs of cryptococcal meningitis testing
and treatment, and 2) to assess the clinical implications and cost effectiveness of testing and treatment
strategies to improve outcomes from cryptococcal meningitis in South Africa. The research team will
populate the novel model structure using data from published literature supplemented by estimates from in-
country collaborators. Intervention strategies will span the cryptococcal meningitis care continuum and will
include improving access to and uptake of lumbar puncture and cryptococcal antigen lateral flow assay
testing, investing in linkage-focused interventions, and expanding access to key treatment drugs (i.e.,
flucytosine and amphotericin B). This proposed analysis will examine the survival benefit and costs
associated with scaling up capacity and distribution for each of these interventions individually and in
combination; results will inform clinicians and policymakers in South Africa and similar settings. Further, the
novel model expansion will provide a platform for investigating additional important clinical and policy
questions related to cryptococcal meningitis and other chronic HIV-associated infections.

Public health relevance
Project Narrative Despite substantially improved access to HIV care worldwide, more than 90,000 people with HIV die each year from cryptococcal meningitis, a treatable HIV-associated infection, because of limited access to testing and treatment. Implementing interventions along the care continuum to address gaps in access to cryptococcal meningitis diagnostics and treatment is critical. With the goal of improving survival for people with HIV and cryptococcal meningitis, we propose to expand the CEPAC-International model to assess the health impacts and costs of cryptococcal meningitis testing and treatment strategies and to determine which combinations of interventions will optimize cryptococcal meningitis health outcomes in South Africa and similar resource-limited settings, given disease distribution and budget constraints.